Training of Neutrophils to Defend Against a Lethal Bacterial Infection of the Lung

PROJECT SUMMARY/ABSTRACT
Hospital-acquired infections are an increasing problem, especially in intensive care units (ICUs), for which the
Gram-negative bacterium, Pseudomonas aeruginosa, poses a serious threat. In patients on life support, P.
aeruginosa can cause ventilator-associated pneumonia (VAP) that is associated with significant mortality
Despite access to new antibiotics, multidrug resistance to P. aeruginosa has doubled over the past 30 years
precipitating an urgent need for alternative strategies for host defense against this pathogen. We undertook a
study with a goal to establish a strategy to improve host defense against PA. We reported that a single low
dose of ultrapure LPS does not induce tolerance but instead the low dose LPS trains the immune system to
mount an effective defense against a lethal P. aeruginosa infection (strain used PA14) with 100% survival.
Without prior LPS exposure, PA14 infection did promote a significant influx of neutrophils to the lung, and yet
the mice succumbed to infection. 2-3 log higher bronchoalveolar lavage (BAL) cells, largely comprising
neutrophils, were recovered from LPS+PA14 mice compared to that from PA14 mice. This suggested that low
level LPS pre-treatment trains lung neutrophils to migrate to the alveolar lumen to effectively handle the
infection. Notably, both mouse and human studies highlight the importance of P. aeruginosa clearance from
the airspaces for increased survival. Investigations of chemokine receptors that might account for the
significantly higher numbers of BAL neutrophils in LPS+PA14 mice show differential expression of CXCR4 in
BAL neutrophils of LPS+PA14 but not PA14 mice. scRNA-seq analysis of lung innate immune cells unraveled
a novel finding that LPS promotes the expansion of a neutrophil population, N3, uniquely enriched in interferon
(IFN)-stimulated genes (ISGs), phagocytosis-associated genes and a cell-killing gene set comprising multiple
genes with anti-bacterial properties including Lgals3, which encodes galectin-3 (gal-3). Analysis of LPS+PA14
gal-3 knockout (KO) mice revealed a significantly higher bacterial burden in the BAL neutrophils compared to
that in control WT LPS+PA14 mice. Also, our ongoing studies show that the LPS+PA14 gal-3 KO mice
succumb to infection after 24h. Cellular metabolism being integral to immune training, examination of gene
expression related to cellular metabolism has revealed selective expression of the glutamine (Gln) transporter,
Slc38a1 in N3 neutrophils and functional analysis supports Gln metabolism in lung neutrophils of LPS-trained
mice. Taken together, these observations lead us to hypothesize that LPS-induced training to defend against a
lethal P. aeruginosa infection involves expansion and sustenance of a neutrophil population, N3, that migrates
to the airspaces in a CXCR4-dependent fashion and engages gal-3 and Gln metabolism to rapidly clear
bacteria and promote host survival. We propose the following two aims to address this hypothesis:
Aim 1. To determine the role of CXCR4 and gal-3 in LPS-induced protective function of airspace neutrophils.
Aim 2. To determine whether LPS-induced protection and training of lung neutrophils involves Gln metabolism.

Public health relevance
NARRATIVE The Gram-negative bacterium, Pseudomonas aeruginosa (PA), promotes a wide range of acute and chronic infections, especially in immunocompromised individuals and in patients on life support causing ventilator- associated pneumonia (VAP) that is associated with significant mortality. We recently reported that pre- exposure to a low dose of lipopolysaccharide (LPS) causes 100% survival of mice from a lethal infection by PA. We identified a unique neutrophil population, N3, endowed with a cell killing gene set that includes the gene Lgals3, encoding galectin-3, in the LPS-treated mice. This proposal seeks to determine the mechanism by which LPS trains the N3 neutrophils in host-defense against PA resulting in 100% survival.